Center for the Study of Complex Malaria in India

DATA MANAGEMENT AND BIOSTATISTICS CORE SUMMARY
The Data Management and Biostatistics Core (“Data Core”) provides data management, statistical and
bioinformatics support for the Center for the Study of Complex Malaria in India (CSCMi). Our system
collects and manages data from all our participating study sites, ensuring uniformity of procedures and high
data quality. Data from our epidemiology projects, hospital-based cerebral malaria project, and sample storage
and tracking data are stored in bespoke REDCap and Freezerworks databases set up and managed by the
Data Core. The Data Core will supervise the transition early in the grant period from paper-based to electronic
tablet-based data capture at CSCMi India sites. Expertise and support for statistical and bioinformatics analysis
and data mapping/visualization are also part of Data Core services. Lastly, the Data Core is responsible for the
rapid release, to PlasmoDB, GenBank, and the broader scientific community, of datasets (genomic as well as
epidemiologic), analysis tools, and other resources that we have generated in adherence to the requirements
and timelines described in the NIAID Data and Reagents Sharing and Release Guidelines, but also in
accordance with Government of India guidelines.